Task D04: World Reference Center for Emerging Viruses and Arboviruses

This contract provides for the development and standardization of nontraditional animal models for infectious diseases and may include candidate product efficacy testing, including GLP studies to support licensure.